ACTG 316--NEVIRAPINE VS NEVIRAPINE PLACEBO FOR PREVENTION OF MATERNAL/FETAL HIV

To date, 5 mother infant pairs have been enrolled in this study at CHOP and its associated perinatal subunits. To date, 3 infants have been born and are undergoing follow-up and data collection. Nationwide, the study has accrued >150 mother-infant pairs to date with a target accrual goal of 1244 mother-infant pairs. No preliminary data are yet available from this study.